Harvard MD Anderson Collaborative to Reduce LyMphatic MOrbidity in Head and Neck Cancer with Artificial Intelligence (HARMONiC-AI)

PROJECT SUMMARY
Head and neck cancers (HNCs) afflict over 65,000 Americans annually, with survivors often battling lingering
complications from treatments like surgery, radiation, and chemotherapy. Notably, lymphedema and fibrosis
emerge as prevalent post-treatment issues. Post-radiation inflammation triggers a cascade—from potentially
reversible soft tissue edema and lymphedema to, more worryingly, permanent fibrosis. About 75% of radiated
patients manifest lymphedema signs within three months, and between 30-50% evolve into moderate-to-severe
neck fibrosis. This progression severely impacts functions like swallowing, speech, and neck movement. The
diagnostic landscape currently leans heavily on manual and endoscopic assessments, which are inherently
subjective and typically catch complications at advanced stages, often when fibrosis is already entrenched.
However, routine head and neck CT scans herald promise for early lymphedema detection. Preliminary research
points to CT indicators, such as CTLEFAT, as potential lymphedema markers. Yet, widespread clinical adoption
remains elusive, primarily due to measurement time and specialized expertise requirements. Our team,
harnessing computational imaging and AI, has pioneered CT-based auto-segmentation of cancer lymphatics
and soft tissue structures. We posit that AI can harness pre-treatment data to tailor treatment plans, minimizing
post-treatment lymphedema (Aim 1). Moreover, we propose that AI-enhanced CT tools can revolutionize
lymphedema diagnosis (Aim 2) and risk assessment (Aim 3), offering precise therapeutic interventions. By
anticipating and addressing the inflammation-to-edema-to-fibrosis sequence, this approach seeks to radically
improve HNC patients' post-treatment quality of life.

Public health relevance
PROJECT NARRATIVE Head and neck cancers (HNCs) leave many survivors confronting persistent post-treatment complications, notably lymphedema and fibrosis. Current diagnostic methods, reliant on manual and endoscopic assessments, often detect these complications late, underscoring the need for early, effective detection tools. Our project leverages advanced computational imaging and AI to refine and enhance CT-based auto-segmentation and classification methods, aiming to revolutionize lymphedema diagnosis, optimize treatment planning, and ultimately improve the post-treatment quality of life for HNC patients.